Deciphering the novel regulatory mechanisms of neovascularization, cardiomyocyte survival, and endothelial cell-cardiomyocyte crosstalk in myocardial infarction

PROJECT SUMMARY
Myocardial infarction (MI) causes 1 of every 7 deaths in the United States. Because the heart has little regen-
erative capacity after injury, an urgent need exists for novel strategies in MI therapy. MicroRNAs (miRs) are
small noncoding RNAs that downregulate targets, and miRs are being pursued as novel therapies for heart
failure in clinical trials. Vascularization is crucial for cardiomyocyte (CM) survival after MI. Ischemic insult re-
sulting from insufficient blood supply to the heart results in reduced myocardial capillary flow reserve and capil-
lary density, impaired tissue perfusion, and augmented cellular injury and scar formation, leading to progres-
sive left ventricular remodeling and chronic heart failure. Because CM renewal is absent in adult mammalian
hearts, dead CMs after MI are also replaced by scar tissue. Although the significance of endothelial dysfunc-
tion and CM dropout in MI has been established, identification of the effectors underlying endothelial cell
(EC) injury, CM dysfunction, and EC–CM crosstalk remains incomplete. Our goal here is to elucidate the
roles of the novel EC- and CM-specific axis in MI. Beta-arrestin-mediated beta2-adrenergic receptor signaling
(beta2AR/beta-arr signaling) elicited myocardial protection and in part contributed to the beneficial effects of
the nonselective beta-blocker carvedilol. We discovered that carvedilol, acting through this mechanism, pro-
moted the maturation of endothelial-enriched miR-532-5p (miR-532). Circulating miR-532 is a potential bi-
omarker for MI. A secreted serine protease called PRSS23 initiates endothelial-to-mesenchymal transition and
is essential for the cardiac valve formation in zebrafish embryo. Using innovative mouse models, we have
made key discoveries: (1) systemic loss of Prss23, a key effector of miR-532, almost completely protects
from cardiac dysfunction post-MI; and (2) systemic, EC-expressed, or CM-expressed miR-532 contributes to
beneficial remodeling in ischemic hearts, which is opposed by EC-derived or CM-derived Prss23. Thus, dis-
secting the pleiotropic mechanisms of action of the miR-532/PRSS23 axis may lead to the development of
novel effective therapies for MI. Our hypothesis is that miR-532 elicits autocrine and paracrine protective ef-
fects on ECs and CMs against ischemic stress by inhibiting maladaptive PRSS23 and cell extrinsic signals. To
test our hypothesis, we plan to pursue three aims: (1) test if PRSS23 is a critical target of endothelial miR-532
and if pharmacological inhibition of PRSS23 promotes neovascularization post-MI; (2) determine the functional
requirement of the CM-derived miR-532/PRSS23 axis during both murine post-MI remodeling and human CM
damage; and (3) elucidate the key paracrine mechanisms by which the miR-532/PRSS23 axis in ECs regu-
lates CM survival after ischemia. This proposal is innovative because the proposed functional axis has never
been studied in a cell-type specific manner or with genetically modified mice. This project also employs trans-
lational human cell and pharmacological studies and is significant because the identified beta2AR/beta-
arr/miR-532-mediated PRSS23 regulatory mechanisms can be exploited as a novel target for MI.

Public health relevance
PROJECT NARRATIVE Myocardial infarction causes over one million deaths in the United States annually and thus there is an urgent need for the novel therapeutic approaches. This project is relevant to the public health goal to develop innovative strategies for prevention and treatment because the discovery of the regulatory mechanisms by the proposed small noncoding RNA–target axis is expected to add a new line of treatment for cardiac pathologies associated with microvascular dysfunction and cardiomyocyte damage. The proposed research is also relevant to the part of NIH’s mission that pertains to developing fundamental knowledge in reducing the burdens of human heart disease.